Project 1

PROJECT 1 SUMMARY
IDENTIFYING METABOLIC VULNERABILITIES REGULATED BY THE P53 FAMILY IN LUNG CANCER
p53 is commonly mutated in all subtypes of human lung cancer. p53 is part of a family of genes that includes
p63 and p73. The functions of p63 and p73 are beginning to be understood in contexts in which p53 function
has been well established including tumor suppression and metabolism. The complexity of p63 and p73 function
is due in part to the existence of multiple isoforms that previously could not be studied independently in vivo. Full
length TA isoforms of p63 and p73 contain a transactivation domain, structurally and functionally resembling
p53, whereas the ΔN isoforms of p63 and p73, while also possessing transactivation activity, antagonize the
activities of p53 and the TA isoforms of p63 and p73. Interestingly, mutant p53, present in a wide variety of
human cancers, has been shown to interact with TAp63 and TAp73 to inactivate their tumor-suppressive
function. This interaction has also been shown to be partly responsible for gain of function activity of p53 mutants.
Moreover, ∆Np63 and ∆Np73, which are amplified in many cancers, including non-small cell lung cancer, bind
and inhibit the activity of p53, TAp63, and TAp73. Lung cancer subtypes also share ∆Np63 driven transcriptional
signatures (Abbas et al., Cancer Research, 2017). We have shown previously that p53 deficient and mutant
tumors can be metabolically reprogrammed to decrease tumor glycolysis and result in tumor regression through
downregulation of ∆Np63 or ∆Np73 (Venkatanarayan et al., Nature, 2015; Napoli et al., Cancer Cell, 2016).
Although our knowledge on the functions of the p53 family in cancer has expanded, their roles in tumor
metabolism are not understood, and the metabolic pathways regulated by the p53 family members in lung cancer
have not been examined. Our overarching goal is to understand the metabolic pathways regulated by the p53
family in lung cancer to develop strategies to target p53 mutant cancers. We have made great strides toward
this goal by generating p63/p73 isoform-specific conditional knockout mice to allow for temporal and context
dependent deletions of each isoform. These tools have allowed us to gain a greater mechanistic understanding
of the interplay of the p53 family in cancer. We have recently demonstrated that conditional deletion of ∆Np63 in
the KrasG12D mouse model of lung adenocarcinoma results in dramatically decreased lung tumor burden.
Additionally, we have found that KrasG12D/+;TAp73∆td/∆td mice develop increased and more aggressive lung
adenocarcinomas that phenocopy mouse models with Kras and p53 mutations, similar to the ones found in
human lung cancer. Lastly, we have developed a novel mouse model of small cell lung cancer (SCLC) lacking
TAp73, which is mutated in 10% of cases. The phenotypes of these mice are associated with changes in key
metabolic pathways including glycolysis and cysteine metabolism. Our primary objective in this application is
to define and understand metabolic pathways regulated by the p53 family in lung cancer. Based on our published
work and preliminary data, we hypothesize that ∆Np63 can be downregulated to metabolically reprogram tumor
cells and the microenvironment to compensate for p53 dysfunction.

Public health relevance
PROJECT 1 NARRATIVE IDENTIFYING METABOLIC VULNERABILITIES REGULATED BY THE P53 FAMILY IN LUNG CANCER p53 is commonly mutated in human lung cancer, including lung adenocarcinoma, lung squamous cell carcinoma, and small cell lung cancer (SCLC), and is part of a family of genes, including p63 and p73, that interact extensively in human cancer. Project #1 will identify metabolic pathways utilizing novel mouse models of lung cancer with p53 gain of function and p63/p73 mutations found in human lung cancer, and cutting-edge metabolomics and genomics techniques to unveil novel therapeutic targets for lung tumors with p53 mutations or alterations in p63 and p73. Project #1 will also identify metabolic pathways regulated by p73, altered in 10% of human SCLC, a recalcitrant disease that lacks targeted therapies.